The effect of a housing mobility program on environmental exposures and asthma morbidity among low-income minority children

Abstract Minority populations in the U.S. are much more likely to be infected with the novel coronavirus SARS-CoV2 and experience severe COVID-19 disease. In this proposal, we leverage our existing cohort of low-income children with asthma who participate in a housing mobility program to characterize rates of SARS-CoV2 infection and disease among participating children and their household members, to explore the relationship between indoor allergen and pollutant exposures, including second-hand smoke and SARS-CoV2 infection and disease, and to assess the impact of pandemic conditions on indoor exposures relevant to asthma among this population. This cohort presents a unique opportunity to study SARS-CoV2 within a cohort of children with well phenotyped asthma and well-characterized indoor exposures.

Public health relevance
Project Narrative Minority populations in the U.S. are much more likely to be infected with the novel coronavirus SARS-CoV2 and experience severe COVID-19 disease. In this proposal, we leverage our existing cohort of low-income children with asthma who participate in a housing mobility program to (1) characterize rates of SARS-CoV2 infection and disease among participating children and their household members, (2) to explore the relationship between indoor allergen and pollutant exposures, including second-hand smoke and SARS-CoV2 infection and disease, and (3) to assess the impact of pandemic conditions on indoor exposures relevant to asthma among this population. We will enroll current and former participants and their household members in this add-on study and collect saliva for SARS-CoV2 antibodies, questionnaire data about COVID-19 disease and exposure, and household dust and pollutant measures over the next year. This cohort presents a unique opportunity to study SARS-CoV2 within a cohort of children with well phenotyped asthma and well- characterized indoor exposures.